Core B - Developmental Core

PROJECT SUMMARY/ABSTRACT
CORE B: DEVELOPMENTAL
The mission of the Providence/Boston CFAR is to promote translational, clinical, behavioral, and basic research
to reduce the incidence of HIV; address comorbidities, co-infections and complications; and develop the next
generation of therapies and research for HIV cure towards Ending the HIV Epidemic (EHE). Our CFAR focuses
on marginalized populations including substance users, men who have sex with men, justice involved persons,
women, gender minority and at-risk youth. As the worldwide HIV epidemic evolves, the Developmental Core
(Core B) is evolving in parallel in order to catalyze innovative scientific leadership. We focus our efforts on early
stage investigators (ESI), trainee and faculty populations who are underrepresented in the biomedical, clinical,
behavioral and social sciences research enterprise, and senior investigators not yet involved in HIV work, so that
they can become the leaders of the future. Our Specific Aims are as follows:
1. Aim 1. Provide short-term funding for HIV/AIDS specific research awards and mentoring for early career
investigators (ESI) and investigators new to the HIV/AIDS research field.
2. Aim 2. Facilitate comprehensive mentoring for HIV/AIDS investigators at all stages of project
development and implementation.
3. Aim 3. Provide state-of-the-art National Research Mentoring Network (NRMN) mentoring training to
CFAR mentors.
Core B will continue to provide essential support for both ESI and established investigators, including timely
funding, creative mentoring, and valuable mentoring training. These efforts will include both the continuation of
existing, effective programs, and the development of several innovations for the next cycle. First, we have
developed a new type of domestic Developmental Grant focused on community-engaged research designed to
lead to future EHE funding. We will implement this new developmental award type in year five of the current
cycle, and continue it in the next cycle, with modifications as needed. Second, we will implement a new Grant
Resubmission Award of up to $10K designed to help those whose NIH grants were favorably scored, but not yet
funded. The goal of the award is to allow investigators to quickly and productively respond to reviewer’s
comments. Third, to foster social and scientific connectedness among developmental award recipients, we will
coordinate a series of meetings (6, 1-hour meetings/year) for awardees whose Developmental Grants are active.
Since 2013, Core B has provided $1.99M of developmental funding which has produced $40.2M in
subsequent NIH funding (ROI of 20:1), and in the last cycle we helped to attract 12 NIH supplemental
awards worth $2.1M. Our existing programs and new innovations, we believe, will help Core B to continue to
further the mission of the Providence/Boston CFAR.